Endosomal Microautophagy in Drosophila

Endosomal Microautophagy in Drosophila
Caring for an ever aging society represents an increasing socio-economic burden and
continuing efforts are required to improve healthspan. Critically, aging is a major ‘risk
factor’ for devastating diseases including cancer, immune and cardiovascular diseases,
as well as dementias due to neurodegeneration, all of which are strongly affected by a
decline in proteostasis. Damaged or altered cytosolic proteins are cleared by the
proteasome and autophagy. Importantly, autophagy has the additional role of providing
nutrients to cells under stress conditions such as starvation, and is thus essential for
energy balance. The removal of damaged organelles and aggregated proteins is thus
essential to protect the nervous system, the liver and kidneys against age related
disorders.
Macroautophagy (MA), chaperone mediated autophagy (CMA) and endosomal
microautophagy (eMI) are the three major forms of autophagy. MA engulfs bulk-regions
of cytoplasm including organelles in a double membrane vesicle (autophagosome).
Autophagosome fusion with lysosomes leads to the degradation of the engulfed material.
CMA and eMI mostly degrade proteins containing a targeting motif (KFERQ related
sequences) that is recognized by the cytoplasmic Hsc70. We have established a genetic
system to study eMI in Drosophila, overcoming a significant hurdle preventing the
characterization of the physiological role of eMI, which previously had only been
characterized biochemically and by EM in mammals. Hence, we can exploit the genetic
power of Drosophila to assess the role of this most recent variant of autophagy.
Using our system, we will determine the physiological function and regulation of eMI. In
particular, we will identify biological processes controlled by eMI. Furthermore, we will
address how kinases we have identified as candidate regulators alter eMI, with a focus on
Drosophila models of human neurodegenerative diseases.

Public health relevance
Project narrative Autophagy, a major way to clear cellular debris, is crucial to prevent accumulation of damaged and non-functional proteins and organelles. Clinically, protein clearance by autophagy is required to prevent many diseases including neurodegeneration at old age. As autophagy declines with age, problems with damaged proteins worsen during life and shorten healthspan. We have established an animal model for endosomal microautophagy (eMI) in the fruitfly Drosophila. eMI is a form of autophagy that can be selective for proteins with a targeting motif and does not require protein unfolding and thus is able to deal with protein aggregates frequently occurring in disease. Having identified eMI in a genetically easily tractable model organism enables us to better characterize the physiological relevance of eMI and simplifies the identification and characterization of novel pathway components with the ultimate goal to identify novel treatment options to improve healthspan.